Promoting the implementation of clinical guidelines for opioid prescribing in primary care using systems consultation

Project Summary/Abstract
The prescription opioids crisis begs for a flexible but generalizable systems-level implementation strategy to
widely improve prescribing practices. A consensus has emerged about safer prescribing practices, but
determining how to implement needed changes remains a challenge. The proposed research will test an
innovative way to implement that consensus, adaptive systems consultation. The research aims to identify
which sequence and combination of implementation strategies works most effectively in promoting practice
change in different primary care clinics. The research serves the long-term goal of learning how to optimize
implementation strategies to promote evidence-based practice in primary care settings. This proposal builds on
a pilot study that tested systems consultation in 4 primary care clinics, which found that systems consultation
was feasible, acceptable, and effective in reducing patients’ average opioid dose (an outcome directly related
to the risk of overdose death). The proposed research tests an adaptive version of the strategy tailored to
different levels (health system, clinic, prescriber). The intervention starts with academic detailing, a systems-
level strategy consisting of an expert-led training session plus distance-based follow-up. This strategy
continues for 18 months and serves as the control condition. At 3 months, half of the clinics will be randomized
to receive practice facilitation, a clinic-level strategy aimed at improving processes related to opioid prescribing.
At 6 months, prescribers will be assessed for guideline concordance, and half of non-guideline concordant
prescribers will be randomized to receive physician peer coaching, a prescriber-level strategy, in which a
physician expert gives one-on-one advice to prescribers in managing their patients on long-term opioid
therapy. These 3 strategies will be delivered in a sequential, multiple-assignment randomized trial to 38 clinics
from 3 Wisconsin health systems. The study compares the effect on average morphine milligram dose of an
adaptive systems consultation implementation strategy (the intervention group) vs. academic detailing alone
(the control group). The study will answer questions about the comparative effectiveness of prominent
implementation strategies (academic detailing, practice facilitation, and physician peer coaching) in a single,
highly efficient study. The study also develops an assessment of the contextual factors that influence the
effectiveness of different implementation strategies and estimates the costs of delivering 4 different sequences
and combinations of implementation strategies. This study will advance implementation science by testing a
multi-level implementation strategy that can be tailored to assess contextual factors influencing
implementation. This fundamental knowledge could be used to help mitigate the opioid crisis and in optimizing
the selection and deployment of implementation strategies used to promote the uptake of many proven but
underused practices throughout healthcare.

Public health relevance
Project Narrative The U.S. is in the midst of an opioids crisis, with drug overdose now the nation’s leading cause of accidental death. The medical community has come to consensus that change is needed with regard to opioid prescribing practices; however, figuring out how to implement the changes that are needed remains a challenge. This study will determine how to implement safer prescribing practices as efficiently and effectively as possible in primary care clinics.